Metabolic and molecular regulation of myeloid cell functions in brain cancer

Glioblastoma (GBM), the most aggressive and lethal form of brain cancer, is characterized by a profound
immunosuppressive microenvironment (TME) that restricts the effects of promising immunotherapies. Therefore,
there is a pressing need to develop more effective interventions to overcome this mechanism of resistance.
Tumor associated macrophages (TAMs) are a mixture of monocyte-derived macrophages (MDM) and microglia
(MG), and they are instrumental for the maintenance of the immunosuppressive state of GBM. However, there
are no effective approaches to overcome the immunosuppressive activity of TAMs in GBM, mainly due to an
incomplete understanding of TAM regulatory functions. Our long term-goal is to dissect targetable metabolic and
molecular mechanisms regulating TAM functions in the context of GBM; as these discoveries will facilitate novel
therapies to target immunosuppression and improve the dismaying outcome of GBM patients. A recent study
demonstrated that TAM are major consumers of glucose and maintain a robust glucose metabolism in the TME.
However, it has not yet been determined how GBM supports the adaptation to glucose metabolism in TAMs
and the functional consequences of this adaptation also remain elusive. Endoplasmic reticulum (ER) stress
activation is associated with the malignant progression of glioma and with the infiltration of anti-inflammatory
macrophages. PKR-like ER kinase (PERK), a critical ER stress sensor, was found to be significantly activated
in human glioma tissues, and its inhibition altered ATP/lactate production by glioma cells. Our preliminary data
expanded these findings indicating that MDM demonstrated highest glucose avidity among MG and neoplastic
cells in GBM tumors, and PERK was strongly activated in GBM infiltrating GLUT1+MDM. Contrary to MG, MDM
exhibited potent immunosuppressive activity. GLUT1+MDM were the only contributors to the suppressive activity
associated with MDM in GBM tumors. GBM-derived factors primed activation of PERK signaling in MDM, which
correlated with metabolic reprogramming resulting in high glycolysis, immunosuppressive functions, histone
lactylation, and no change in histone acetylation. Based on our crucial observations, we hypothesize that a
PERK-driven perturbation of glucose metabolism in MDM governs their immunosuppressive functions via
lactate-derived lactylation of histone lysine residues. We will test this hypothesis through the following aims:
Aim1: to elucidate underlying mechanisms of how PERK governs glycolysis in MDM in GBM tumors; Aim2:
to define glucose-driven epigenetic modifications that regulates immunosuppressive programs in MDM;
Aim3: to investigate the therapeutic potential of an epigenetic targeting approach to modulate the functions
of TAMs in GBM. The proposed studies are highly innovative because they will elucidate a previously
uncharacterized link between ER stress and glucose metabolism that regulates the activity of TAMs via
epigenetic mechanisms. Our proposal will provide a mechanistic rationale for the development of novel
therapies to target immunosuppressive TAMs and enhance the efficacy of immunotherapy in GBM patients.

Public health relevance
PROJECT NARRATIVE Glioblastoma is an incurable primary malignant brain cancer and is characterized by a profound immunosuppressive microenvironment which renders this cancer highly resistant to immunotherapy. The proposed studies will exert a profound effect in the field by dissecting targetable metabolic and molecular mechanisms regulating the function of tumor associated macrophages, which are instrumental for the maintenance of immunosuppressive state of glioblastoma. This mechanistic understanding will be critical to provide our clinical partners with novel therapeutic approaches to overcome immunosuppression and to enhance the efficacy of immunotherapy in GBM patients, which will be tested in subsequent clinical trials.